FOOD (Food to Overcome Outcomes Disparities)

Project Summary
The World Health Organization defines food security as having access to sufficient, safe, nutritious food to
maintain a healthy and active life. Food security includes both physical and economic access to food that
meets people's dietary needs and preferences. The 18-item, 12-month time-referenced U.S. Household Food
Security Survey Module (USDA) categorizes individuals as having high food security, marginal food security,
low food security, or very low food security. Food insecurity is growing in the U.S., with an overall prevalence of
12.7% (low and very low food security). The prevalence of food insecurity among immigrant and minority
communities exceeds the national average. Food insecurity is associated with non-adherence to treatment.
Food-insecure patients are more likely to postpone care and often cannot afford prescribed medication(s).
Food-insecure patients have significantly higher levels of nutritional risk, depression, financial strain, and lower
quality of life. Nutrition interventions result in enhanced quality of life. Cancer patients are particularly
vulnerable to both food insecurity and its impact, due to the intensity of treatment protocols and the disease
process itself. A study among a cohort of underserved cancer patients in New York City showed that 56% were
food insecure, with 38% of the cohort with very low food security. Treatment adherence is an important
determinant of survival among cancer patients. However, among ethnic minority cancer patients, unmet
socioeconomic and supportive care needs are associated with patient-reported missed radiation, and/or
chemotherapy appointments. Food insecurity potentially acts as a mediating factor, as functional, social, and
emotional well-being decrease significantly with increasing food insecurity. Prior to our work, there had been
only one study examining food insecurity in cancer patients. There is to date no evidence base on
interventions to address food insecurity, and their potential to ameliorate cancer and other chronic disease
treatment completion disparities. Food to Overcome Outcomes Disparities (FOOD) addresses this gap as the
first large study of its kind to examine food interventions in vulnerable populations and their impact on breast
cancer treatment completion. Results have the potential to guide program and policy change. FOOD will utilize
a three arm randomized controlled trial to assess the impact of a hospital-based medically tailored food pantry
(Pantry) versus a food voucher program (Voucher) versus a home grocery delivery program (Delivery) on
cancer treatment completion. FOOD is a partnership between the Memorial Sloan Kettering Cancer Center
(MSK) Immigrant Health and Cancer Disparities (IHCD) Service, the Food Bank for New York City, the New
York City Council, the New York City Health and Hospitals, God's Love We Deliver, and Saint Barnabas
Hospital. This study builds upon the foundation laid by a seminal pilot feasibility randomized controlled trial,
which examined a scalable, clinic-based food pantry, a food voucher program, and home grocery delivery.

Public health relevance
Project Narrative This is the first study to address the impact of food insecurity among the growing underserved, and immigrant and minority, breast cancer patient population in active treatment for cure. The FOOD study builds upon the team's unique approaches to addressing and studying food insecurity and cancer treatment completion, including implementing food pantries co-located within oncology clinics and studying the impact of a pilot food voucher program and a home grocery delivery program. FOOD has the potential to significantly improve the growing issues of food insecurity and barriers to emergency food resources that hamper breast cancer treatment completion among medically underserved populations in New York City, and across the nation in large metropolitan areas.